FLASH-pulse: A versatile multiplexed tissue imaging solution for research on aging

Project Summary
Addressing the complexities of age-related disorders at the cellular and molecular level requires
a spatial omics technology capable of rapidly and reliably mapping the distribution of
specific cell markers within tissue at the subcellular scale. While spatial proteomics
technologies have revolutionized in situ molecular profiling of tissues, limitations in resolution,
throughput, sample degradation, and cost have hindered their widespread impact. This is the
focus of our project, which proposes to develop FLASH-PAINT, a disruptive proteomics
technology, into FLASH-pulse, an automated and multiplexed imaging solution specifically
tailored for FFPE tissue samples. Our proposed technology promises to provide scientists with a
simple method to perform exceptionally rapid 32-plex protein imaging on their tissue
samples using a microfluidics chamber designed for easy integration with standard
benchtop microscopes and necessitating minimal experimental intervention on their part.
FLASH-pulse is distinguished by its elimination of washing steps, thereby preventing sample
degradation and enabling the rapid collection of highly multiplexed imaging data of large tissue
sections1 cm2 tissue. Panluminate, Inc. is a leading company in the spatial proteomics space.
Our proposed project aims to develop FLASH-pulse and validate it in human FFPE tissue. We
specifically propose to (1) develop a new concept and prototype for microfluidics tailored for
FLASH samples that removes the need of traditional big-footprint microfluidics, (2) develop new
FLASH probes designed for high signal-to-background imaging in FFPE tissue, and (3) test this
system in a testbed application of aged and young human lymphoid tissue. Ultimately, the
developments proposed here will enable panluminate to disseminate FLASH-pulse imaging to
every research and biotech lab around the world.

Public health relevance
Project Narrative Understanding the intricate functions of normal aging at a molecular level, particularly how individual cells and their microenvironment interact over time and space, will provide new insights into cellular mechanisms disrupted in age-related diseases. In this project, we will develop FLASH-pulse, the first automated subcellular spatial proteomics platform technology that is capable of multiplexed data generation on the scale of minutes versus hours, and validate its applicability in young and aged formalin-fixed, paraffin-embedded human lymphoid tissue. This development is crucial for advancing public health as it aims to transform the way we identify, treat and prevent a range of age-related disorders, opening new horizons in biomarker discovery and therapeutics.